Task C21: Compound Synthesis - Nonclinical Services for Development of Interventional Agents for Infectious Diseases

This contract provides for chemistry and manufacturing services under the NIAID Preclinical Services for the Development of Interventional Agents Program.